THERMODYNAMIC PROPERTIES OF NADH: NITRATE REDUCTASE

The goal of the proposed research is to determine the mechanism of electron transfer and thermodynamic properties of the enzyme, assimilatory NADH:nitrate reductase under various environmental conditions. Specific aims are to determine: 1) oxidation-reduction (redox) potentials of the prosthetic groups FAD, heme, and molybdenum; 2) the effect of pH, ionic strength, substrates, and effectors on the redox potentials; 3) the stoichiometry and intermediate redox states in the transfer of electrons from NADH to nitrate; 4) the pathway and transient state kinetics of electron transfer between NADH and nitate; 5) magnetic interactions between prosthetic groups; 6) physical and functional interactions between nitrate reductase and the next enzyme in the pathway of nitrate assimilation, nitrite reductase. For these studies we will utilize EPR spectroscopy, UV/VIS-dual wavelength spectroscopy, microcoulometry, freeze-quench and stopped-flow techniques, and substituted analogues of nitrate reductase. These studies will provide important information on the mechanism of catalysis by nitrate reductase and factors which influence this activity. Since this enzyme catalyzes the rate-limiting step in the process of nitrate assimilation, the proposed research is of importance in terms of plant productivity and the supply of protein. This enzyme also serves as a model system for more complex electron transfer systems.